Fatty Liver Disease in African Americans

Obesity is a major health concern that is increasing in prevalence in the U.S. and worldwide, and
disproportionately affects African Americans. It can lead to non-alcoholic fatty liver disease (NAFLD), which in
turn can lead to liver cancer via chronic hepatitis, but the malignancy is asymptomatic until late stage when
curative options are unavailable, leading to extremely high mortality. On the other hand, increasing knowledge
of the mechanistic pathways by which NAFLD leads to cancer offers the possibility to develop early serum
markers that can stratify patients into those at higher and lower risk: in turn, higher risk patients can undergo
liver cancer surveillance to identify it early enough for curative surgery. The present proposal is a collaborative
approach for research at Howard University (HU) and the Lombardi Comprehensive Cancer Center (LCCC) at
Georgetown University to discover the molecular and genetic signatures of perturbed metabolic and
mechanistic pathways in NAFLD patients in an African–American (AA) population receiving medical care for
this condition at Howard University Hospital. Our overall objective is to identify candidate genes and
genetic pathways associated with NAFLD, to find and fill the knowledge gaps of this extreme health
disparity issue among AA around the Washington DC region. The two PIs of this pilot study – Dr.
Christopher Loffredo, a cancer epidemiologist at LCCC, and Dr. Charles Howell, a gastroenterologist and Chair
of Internal Medicine at Howard University – will co-mentor Dr. Ghosh, an early stage investigator at HU. Dr.
Ghosh's expertise is molecular genetics of chronic diseases. Leveraging these complementary areas of
expertise, we propose to use pilot funding from this P20 proposal to enroll 50 NAFLD patients (cases) and 50
matched controls at Howard University: they will participate in an interview to provide information on personal
and medical history, and will agree to a blood draw that will allow us to assess differences in levels of gene
expression in cancer-relevant mechanistic pathways (e.g. inflammation) that are potential signatures of
disease progression towards liver cancer. We will actively involve graduate and post-doctoral students in the
laboratory work. In Specific Aim 1 we will apply a gene expression analysis (microarray coupled with IPA
analysis) to divulge the differential gene expressions and their pathways in the two groups of subjects. In
Specific Aim 2 we will validate the candidate disease markers by applying high-throughput TaqMan® Low
Density Arrays (TLDA). We will validate the precise panel of genes within the particular biological pathways
and we will integrate clinical, epidemiologic and laboratory data to identify the robustness of these markers
towards stability, validity, reproducibility, feasibility and utility of this new TLDA approach. The overreaching
goal of this research is, therefore, to shed new light on possible mechanisms by which NAFLD may contribute
to the dysregulation of important pre-cancer pathways. In turn, such knowledge will foster the identification of
potential avenues for treatment and prevention for this minority population.

Public health relevance
Non-alcoholic fatty liver disease (NAFLD) disproportionately affects African Americans, and in turn can lead to liver cancer via chronic hepatitis. On the other hand, increasing the knowledge of the genetic pathways that are affected by NAFLD, as we propose to discover, offers the possibility to develop early serum markers that can stratify patients into those at higher and lower risk of the disease.